Cancer Research Training and Education Coordination

CANCER RESEARCH TRAINING AND EDUCATION COORDINATION - ABSTRACT
The Cancer Research Training (CRT) Office within the University of Hawai‘i Cancer Center (UHCC)
coordinates research education, training activities, and educational opportunities for UHCC staff and trainees.
CRT offers cancer research education throughout the catchment area, which includes high school,
undergraduate, graduate, medical students, postdoctoral fellows, junior faculty, clinicians, and healthcare
professionals. During the last five years, CRT has more than tripled its annual funding base through several
institutional training grants. More than 290 trainees (68% women and 32% men, 33% from under-
represented minority groups) were mentored in cancer biology, experimental therapeutics,
biostatistics/bioinformatics, nutrition, epidemiology, behavioral and community interventions. CRT also
supports faculty, staff, and trainee travel to scientific meetings, workshops, and related activities. Our overall
goal is to strengthen UHCC as the central cancer research education hub within Hawai‘i and the Pacific and to
provide innovative training and mentorship experiences focusing on diversity and health disparities at all career
levels. This is done in close collaboration with the two Programs, Cancer Biology (CB) and Population
Sciences in the Pacific (PSP), the Shared Resources, the Clinical Trials Office (CTO), the Community
Outreach and Engagement (COE) Office, and the Diversity, Equity, and Inclusion Office (DEI). In service of this
goal, we propose the following specific aims: Aim 1. Develop and implement innovative education initiatives to
train cancer disparity researchers from diverse backgrounds at all career stages in the catchment area of
UHCC. Aim 2. Increase skills in cancer research through programs appropriate to different career levels, from
introductory curricula for high school and undergraduate students, research experiences for graduate students
and postdoctoral fellows, programs for medical and clinical trainees, to mentoring for junior faculty. Aim 3.
Evaluate cancer research training activities through long-term tracking of participants using alumni surveys and
data collection from relevant databases to assess educational and career outcomes. From high school to junior
faculty, CRT offers opportunities to develop careers in cancer research with a focus on diversity, equity, and
integration across racial and ethnic groups, and on distinctive opportunities in the Pacific region. By engaging
and inspiring diverse cancer professionals, the CRT will enhance the diversity of the workforce and improve
the quality of cancer research in the catchment area. All activities are designed to achieve CRT Office’s vision
to educate and mentor the next generation of scientists and clinicians who will reduce cancer health disparities
in Hawai‘i and the Pacific through innovative basic, behavioral, clinical, translational, and population sciences-
related research.